SCHARE DATA SCIENCE PLATFORM COMMUNICATIONS SUPPORT

DATA SCIENCE PLATFORM COMMUNICATION SUPPORT (ScHARe) will fill a gap in NIH repositories focusing on social science data (SDoH), is will be a platform for the development of bias mitigation tools by users, and fulfill NIH Data Sharing policy for health disparity (HD), SDoH and healthcare delivery investigators/grantees and intramural investigators. Knowledgeable skilled cloud developers and data curators are needed to expedite the completion and launch of the ScHARe resource. In addition, HD and SDoH core data elements to increase interoperability and training of new underrepresented users are critical to increasing a diverse AI workforce and promote the use of big data to further understand Health Disparities, especially the role of SDoH.